Parallel Excitation Methods for High Field MRI

Abstract High field MRI (3T, 7T and above) offers many potential advantages to clinical and scientific studies, including increased sensitivity and improved image contrast creating the potential for improved characterization of biological function and anatomy in health and disease. Parallel transmission (pTx) uses multiple excitation coils driven by independent RF pulse waveforms to subdivide the transmit field into multiple spatial regions each controlled by a separate transmit channel. Increasing the number of spatially distinct transmit elements and using temporally distinct RF pulse waveforms creates spatial degrees of freedom that allow the spatial pattern of the array to be exploited in the excitation process. Previous pTx work by ourselves and others has concentrated on the potential to utilize this additional flexibility to move beyond the uniform slice-select excitation. In the current proposal, we propose a program of translational bioengineering development to widely impact 3T clinical imaging and facilitate the advance of 7T clinical imaging by develop and validate novel methods to increase the degrees of freedom available in pTx pulse design together with novel optimization schemes which can convert these degrees of freedom into reduced SAR. Successful implementation of such methods potentially allow us to expand the quality of clinical imaging by providing more slices, higher flip angles, or shorter TR periods in a wide range of clinical protocols. Additionally we will develop methods which directly address the local SAR problems of the more exotic 2D and 3D spatially tailored pulses, which has proven to be a major limitation of these pulses. Finally we provide a theoretical and experimental validation of the SAR models in ubiquitous use.

Public health relevance
Project Narrative This bioengineering project seeks to develop translational technology to improve Magnetic Resonance Imaging (MRI). Its ultimate goal is to provide improve the MR images used for clinical diagnosis of disease and to increase the ability of MR as a scientific tool for studying anatomy and function within the living human body in health and disease. __SpecificAimsTextDelimiter__ SPECIFIC AIMS High field MRI (3T, 7T and above) offers many potential advantages to clinical and scientific studies, creating the potential for improved characterization of biological function and anatomy in health and disease. Our previous 4-year cycle of this grant successfully concentrated on developing and validating RF pulse and transmit coil methods which utilized the added degrees of freedom offered by parallel transmit (pTx) hardware to mitigate the spatial flip-angle (and thus image contrast) inhomogeneities intrinsic to the short RF wavelength in the human head at 7T and body at 3T. Unlike detection inhomogeneity that manifests primarily as image shading, a non-uniform transmit B1+ field results in spatially dependent tissue contrast and SNR and therefore reduced diagnostic power. We successfully developed and validated parallel transmit methods capable of mitigating the severe B1+ inhomogeneities (>2.5 fold) at 7T with spatially tailored 2D and 3D accelerated transmit trajectories, including short-duration (<3ms) slice-selective pulses and workflow solutions for checking local Specific Absorption Rate (SAR) of each pTx pulse prior to use. In the current proposal, we concentrate on a different, perhaps even higher impact use of parallel transmit technology. We focus on developing pTx to overcome the SAR limitations present in single- channel body RF coil excitations. In short, we develop, implement and validate pTx methods to lower SAR (especially local SAR) for routine clinical applications at 3T and 7T. Successful implementation of such methods broadly impacts the quality of clinical imaging by providing more slices, higher flip angles, or shorter TR periods in a wide range of clinical protocols while still satisfying regulatory limits on SAR. Additionally we will develop methods which directly address the local SAR problems in emerging and more exotic 2D and 3D spatially tailored pulses, which has proven to be a major limitation of these pulses. For all aims methods will be validated in simulation and experimental studies. Aim 1 Develop and validate pTx pulse design optimization methods which directly penalize local SAR as well as excitation strategies which reduce time-averaged local SAR by forcing hot-spots to "hop around" spatially. a) Regularization during pulse design We extend pTx pulse design optimization to explicitly penalize local SAR. The methods stem from our novel compression algorithm which dramatically compresses the parameter space to a set of "Virtual Observation Points" (VOP) to quickly calculate local SAR within a user- specified error margin. The VOP method is critical since it is computationally prohibitive to penalize SARlocal on an exhaustive 3D spatial grid, and avoid simply moving the location of the hotspot. Additionally we provide, for the first time, a lower bound on the obtainable peak local SAR given the fields and pulse design parameters. We incorporate this for guiding difficult, non-convex optimizations. b) Reducing time-average SAR We develop algorithms to purposely generate families of pTx pulses with similar spatial excitation patterns but maximally differing local SAR patterns. Using each pulse for a different imaging slice or phase encode step, the local SAR hotspot will jump around spatially avoiding coherent time averaging, thus spatially distributing the local SAR load over the duration of the acquisition. Aim 2 Develop and validate local-SAR minimizing excitation strategies to exploit, a) the degrees of freedom offered when Narray elements > Ndriving channels; and b) the gyrotropic nature of MR excitation. a) Mode compression The extra degrees of freedom gained in forming and choosing the modes used by a limited number of independent transmit channels will be applied to improve pulse performance (spatial fidelity, efficiency and SAR). We will develop and test algorithms for choosing the modes and validate the strategies in prototype transmit arrays. b) E field cancelation with "Dark modes" We develop and validate a strategy to cancel the peak local electric fields responsible for local SAR hot-spots. Since some modes of an array coil (e.g. those with the wrong circular polarization) produce E fields but not useful excitation of the MR magnetization, we can energize these modes exclusively with the goal of cancelling local SAR hot-spots. We will validate the algorithms and coil geometries we develop in prototype transmit arrays. Aim 3 We develop new frequency domain approaches to considerably speed up the numerical estimation of electro-magnetic fields in the body. The methods utilize pre-computed, human-head specific Green's functions and parameter compression methods allowing accurate and extremely efficient calculation of E and B fields in the body in <1min. The goals of the accelerated computations are to: a) Optimize RF arrays geometries over a broad parameter space using B1+ and SARlocal as metrics. b) Provide stochastic analysis of variations in SAR over a range of model variations such as subject positions and distribution of electrical properties in tissues classes. We validate our SAR models with MR based thermometry using Tm:DOTMA in a novel anatomical head phantom.